Identifying integrated circuit mechanisms of PTSD: Multimodal neuroimaging fusion of fear inhibition and cognitive control

Posttraumatic stress disorder (PTSD) is a prevalent and debilitating neuropsychiatric consequence of
military combat, representing a significant burden for many Veterans. PTSD is also a highly heterogeneous
disorder, with symptoms varying from patient to patient—complicating clinical decision-making. The
diversity in symptom presentation has led to a growing interest in developing a biologically-grounded
framework for neuropsychiatric disorders, where the focus is on symptoms, not diagnostic categories, and
where symptoms are a consequence of dysfunctional neural circuits. Symptom-derived biomarkers can then
guide precision medicine approaches by identifying the underlying symptom-specific neural circuits that are
most sensitive to specific treatments. Yet, much of what we know about the circuit pathology associated with
PTSD comes from comparing diagnostic groups on a single mechanism using a single neuroimaging measure.
These univariate neuroimaging approaches precludes identification of the more complex relationship
between neural mechanisms and PTSD symptoms. This complexity underscores the need for an integrated
and multivariate approach to probe multiple neural circuit mechanisms underlying specific PTSD symptoms.
The current proposal aims to address this gap by measuring the combined contribution of two critical
mechanisms of PTSD: 1) the ‘top-down’ cognitive control over working memory (WM) storage, and 2)
‘bottom-up’ inhibition of fear responses during fear extinction recall. First, we posit that misallocating WM
resources to task-irrelevant threat may help partially explain the trauma-related intrusive memories, and
inability to extinguish fear responses that are characteristic of individuals with PTSD. To investigate this,
Veterans (N=85) that have experienced a criterion-A trauma and have mild to severe levels of PTSD
symptoms will complete separate measures including an affective WM task and a fear extinction recall
paradigm while undergoing fMRI. The first goal of the project will be to use fMRI to test our hypothesis that
Veterans with elevated PTSD symptoms unnecessarily maintain threat-distracters in WM and consequently
diminishing WM capacity. The second goal will be to identify the common neural circuit underlying WM
control and fear extinction recall. The primary goal of the study will be to test the hypothesis that the neural
integration between WM and fear extinction recall dysfunction predicts PTSD symptom clusters. To
investigate this last goal, we will use an innovative multivariate neuroimaging analytic strategy called
multimodal neuroimaging fusion. Multimodal fusion analysis allows for the identification of unique and high-
dimensional neural patterns among multiple neural measures and PTSD symptoms that a univariate
approach would miss. This project will be one of the first studies to apply a multimodal neuroimaging fusion
analysis in a Veteran PTSD population. Results from this project will lay the groundwork for establishing and
validating the multimodal approach to develop biomarkers of PTSD symptom heterogeneity within cognitive
and extinction-based mechanisms, two mechanisms that are clearly integral to current PTSD treatments.
Building upon the applicant’s prior experience with neural measures of WM dysfunction in anxiety, the
proposed training plan provides an opportunity for new hands-on training in fear learning methodology,
multimodal neuroimaging, and advanced multivariate neuroimaging analysis to meet the immediate goal of
developing skills in these domains. This dovetails with the long term career goal for the candidate of
developing of expertise in the integration of multiple neuroimaging modalities for the purpose of enhancing
clinical utility of neuroimaging for PTSD diagnostic assessment and treatment prediction. Data from this
project will provide critical and direct pilot data for successful preparation of a VA Merit Award. Together, the
research and training plan will make the applicant well-positioned to transition to an independent clinical
researcher within the VA system.

Public health relevance
The proposed CDA-2 will provide Dr. Stout with the training, expertise and research support to examine the relatively unexplored neural circuit relationship between working memory and fear extinction, and how these mechanisms jointly contribute to posttraumatic stress disorder (PTSD). This project will be one of the first to leverage innovative multivariate neuroimaging analysis to better elucidate the symptoms of PTSD. The planned CDA-2 aims to create more robust neural circuit biomarkers that can be used to delineate the individual neurobiology of Veterans with PTSD. These aims support the VA mission of developing precision medicine tools for Veteran care and the identification of viable targets of treatment for PTSD and other trauma- related disorders.